SERVICES TO EXTEND METHODS FOR RISK PREDICTION WITH A CONTINUOUS TIME MODEL FOR SURVIVAL UNDER COMPETING RISKS

THIS PURCHASE ORDER INCLUDES SERVICES TO EXTEND METHODS FOR RISK PREDICTION WITH A CONTINUOUS TIME MODEL FOR SURVIVAL UNDER COMPETING RISKS USING TWO-TIME SCALES